Boston Speech Motor Control Symposium

PROJECT SUMMARY
Although speech production is arguably the most complex—yet routine—motor skill that humans perform, there
are only two major conferences in this area. Both, we argue, occur relatively infrequently and are prohibitively
expensive for many students, clinicians, and faculty members. Because academic conferences are an invaluable
opportunity to make professional connections, disseminate findings, and exchange ideas, there is a need for
more options to share research on speech motor control. The goal of this R13 application is to renew support for
the Boston Speech Motor Control Symposium (BSMCS), an intentionally accessible and inclusive regional
conference that augments current meetings in speech motor control. The research presented at BSMCS each
year furthers the mission of the NIH by contributing to basic and practical knowledge surrounding the
manifestation, causes, treatment, and prevention of disorders of motor speech production throughout the
lifespan. BSMCS specifically draws on the high concentration of individuals in the Boston metropolitan area and
areas surrounding Boston that are reachable by car and train; the conference is designed to reduce barriers to
attendance for these individuals to effectively expand the pipeline of promising underrepresented minority
researchers. This includes low registration fees, short conference duration (two days), access to on-site childcare
and lactation rooms for working parents, and virtual attendance options. BSMCS additionally aims to continue
decreasing barriers to accessibility and diversity, inclusion, and equity (DEI) to the field by providing travel awards
to trainees (students and post-doctoral scholars). As a hybrid conference, BSMCS is also appealing to speech-
language pathologists, who often face the challenge of funding the continuing education needed to maintain their
clinical competency. Not only will BSMCS offer continuing education units to appeal to those in the clinical field
(in person or virtual), but virtually attending BSMCS will provide speech-language pathologists with affordable
access to high-quality emergent research, thereby facilitating the application of the latest research findings in
clinical care. The primary purpose of this R13 conference grant proposal is to request funding support for travel
fellowships, poster awards for selected trainees and early-career researchers, travel and accommodation
expenses for out-of-town invited speakers, family care provider expenses, conference supplies (e.g., e-poster
services), and administrative support in the coordination of BSMCS. NIDCD support will allow BSMCS to meet
the goals of DEI and accessibility, thereby bolstering the pipeline of underrepresented minorities in speech motor
control and exposing clinicians to cutting-edge research that can be applied to facilitate clinical care of individuals
with motor speech disorders.

Public health relevance
PROJECT NARRATIVE The Boston Speech Motor Control Symposium (BSMCS) is a regional conference that aims to provide an accessible and inclusive environment to share research in speech motor control. The conference—scheduled to occur in June in 2025, 2027, and 2029 at Boston University—offers low registration fees ($60, or $30 for students), a concise two-day duration, on-site childcare and lactation rooms, virtual attendance options, travel awards for trainees, and continuing education units for speech-language pathologists, all aimed at enhancing accessibility, diversity, and professional development within the field. The research presented at BSMCS each year furthers the mission of the NIH by contributing to basic and practical knowledge surrounding the manifestation, causes, treatment, and prevention of disorders of motor speech production throughout the lifespan.